CVD and inflammation across the lifespan in HIV infected adults and children

DESCRIPTION: We have little understanding of how the epidemiology of cardiovascular disease (CVD) and the value of CVD risk factors may evolve with aging in the HIV-infected population. Now that HIV has become a lifelong condition with the advent of effective antiretroviral therapy, this is of great concern. If risk factors for CVD are to be applied for cliical risk stratification in a evidence- based fashion, better data are needed across the age spectrum. The overarching goal of this proposal is to study how determinants of CVD change with aging among HIV-infected persons. Prior cohort studies, by applying similar research approaches to many cohorts across the age spectrum, have revealed much about the influence of age on the epidemiology of CVD. As has long been recognized, not only does CVD risk increase with aging, but the risk factors for CVD differ across early and later life. For example, while elevated cholesterol is unquestionably a causal CVD risk factor, in older adult's serum cholesterol levels have a weak, inconsistent relationship with incident and prevalent CVD. Elevated blood pressure (BP) and C-reactive protein, also known CVD risk factors, likewise are profoundly age-dependent. These phenomena have not been studied in the HIV-infected patient population. We plan an R21 proposal that will significantly extend and build upon the NHLBI HIV-CVD Consortium, which includes 9 R01 investigations on atherosclerotic CVD in adults and children with HIV. Coordination is provided by a Data Coordinating Center (DCC), Central Laboratory, and 3 specialized Reading Centers that have measured CVD risk factors, blood biomarkers, and noninvasive vascular images in identical fashion in the Consortium's nearly 5,000 enrolled subjects. Scientific aims will involve the identification of risk factors, including standard clinial CVD risk factors such as lipids, blood pressure and diabetes, as well as novel biomarkers of inflammation and hemostasis that are associated with the presence of subclinical atherosclerosis in patient groups across the lifespan from adolescence, through young-to- middle adulthood and later decades of adulthood.

Public health relevance
PUBLIC HEALTH RELEVANCE: Infection with HIV has become less likely to lead directly to death due to improvements in anti-retroviral therapy, but this improvement has resulted in an increase in cardiovascular events among HIV-infected patients. There has not previously been a careful study using cohort data with the potential to look at how this increase in cardiovascular risk varies based on age at HIV infection. By grouping together many of the premier cohorts in the HIV world, we hope to shed light on the sub-clinical changes in cardiovascular risk and how these changes influence cardiovascular risk across the life-span. __SpecificAimsTextDelimiter__ Compared with HIV-uninfected persons, HIV infected patients have excess cardiovascular disease (CVD) risk which appears to be mediated by inflammation, immune perturbation, hemostatic imbalance, as well as traditional CVD causes such as widespread smoking. As HIV patients achieve increasingly higher ages with effective antiretroviral therapy (ART), it is critical to study the burden of CVD and its risk factors among contemporary, treated patients across different age strata. Prior NHLBI studies of non-HIV-infected patients, by applying similar research methods to cohorts of different ages, have revealed much about the influence of age on the epidemiology of CVD. We now recognize not only that CVD risk increases with aging, but specific CVD risks vary in nature by age. For example, while elevated serum levels of pro-atherogenic lipids are unquestionably causal factors in pathogenesis of CVD, in the general older adult population lipids have a weak inconsistent relationship with CVD. Elevated blood pressure (BP) and diabetes also have age-dependent associations with CVD in the HIV-uninfected elderly. Several barriers have precluded informative studies of aging, HIV and CVD: 1) HIV cohorts are often drawn from specific recruitment pools (e.g., outpatient clinics), and individual cohorts may have narrow inclusion criteria, so that they lack sufficient diversity in age and other demographics. 2) Relationships among CVD risk factors change with age. Thus, many variables, each of which are independent risk factors for CVD and at the same time may modify other CVD risk factors, must be examined together. For example, dyslipidemia, inflammation and medication use are an established triad of CVD risk factors that are associated with HIV - each of these factors changes with age, each may affect the others, and each independently affects CVD risk. 3) Over many years with HIV infection the nature of risk factor-CVD associations evolves, apart from the effects of age. We have shown that D-dimer, IL-6, and lipid levels predict increased carotid artery wall thickness in ART-treated HIV-infected patients, but not in patients who are not using ART. 4) Adequately-powered studies require large sample sizes to conduct meaningful age subgroup analyses, while also accounting for all covariates noted above. 5) Differences in methodologies make it difficult to compare across studies (e.g., older versus younger cohorts). In addition, studies finding null associations between CVD risk factors and CVD outcomes are less likely to have been published ("file drawer bias"). Thus, meaningful data pooling or meta-analysis using existing literature has been challenging. 6) Prior studies that have included untreated HIV infected patients are not relevant to today's ART-treated patients. Our overarching goal is to study how CVD determinants among HIV-infected persons change with age. This R21 builds upon the NHLBI HIV-CVD Consortium, which includes multiple R01 grants on CVD in HIV-infected adults and children and HIV-free controls. A Data Coordinating Center and specialized Core Labs have overseen measurements of CVD risk factors, blood biomarkers, and vascular imaging that were conducted similarly across thousands of enrolled HIV-infected participants. Our cohorts include N=2,612 HIV-infected persons with identical carotid ultrasound (CIMT) measures, N=1,049 with identical coronary artery calcium (CAC) measures, and N=4,487 with identical laboratory measures of inflammation/coagulation. We propose: 1. To examine influences of age on inflammation, coagulation, and traditional CVD risk factors in HIV infected persons. We hypothesize that increasing age will be associated with increasing inflammation/ coagulation biomarkers. Across middle-to-late adulthood (beyond age 55 years), decreasing serum lipid levels, BMI, and diastolic BP will be observed. These phenomena will be observed at younger ages among HIV-infected adults, as compared with HIV-uninfected controls. Adjustment for ART, current and nadir CD4+ T cell count and current and peak HIV RNA will distinguish effects of age from HIV disease stage. 2. To examine whether age modifies associations between vascular disease (carotid artery intima- media thickness and coronary artery calcium) and HIV infection, CVD risk factors, and inflammation. In the general population, not only do older adults experience a drop in serum lipids and diastolic BP due to hemodynamic changes, inflammation and malnutrition, but in the elderly these factors lose their ability to predict CVD risk. We hypothesize that as compared with younger persons, among adults 55+ years old dyslipidemia, BP, BMI, and inflammation have relatively weaker associations with carotid and coronary artery disease measures. We anticipate that the age at which these CVD risk factors lose their power to predict CVD will be younger among HIV-infected persons compared with the HIV-uninfected population. IMPACT: This study will clarify associations between vascular disease and HIV-related and traditional CVD risk factors in HIV-infected persons across a wide spectrum of age - an innovation made possible by our unique Consortium data. Completing these aims will help to achieve the long-term goal of targeting CVD prevention and screening efforts on HIV-infected persons at greatest risk. We also will identify the risk factors that are most predictive of subclinical CVD, and we hypothesize that these may differ between adolescents, middle-aged adults and 55+ year old adults - thus identifying the most promising targets for interventions. 1